National Center of Rabbit Models for Translational Research

PROJECT SUMMARY: Rabbits offer great potential as translationally relevant models of human disease for
many biomedical research applications thanks to their evolutionarily closeness to humans, favorable
reproduction features, relatively long lifespan which allows for clinically relevant studies, a body size that is
similar to that of human infants allowing for more relevant surgical models, and an economically feasible
housing cost in a research setting. Rabbit models have been critical to diverse scientific breakthroughs, such
as the development of in vitro fertilization techniques, the HPV vaccine, and a multitude of antibodies for
various scientific applications. Over the last 30 years, rabbits have been surpassed by mice in part due to ease
of generating genetically engineered mice from embryonic stem cells (ESCs), which are not available in
rabbits. CRISPR/Cas9 has made it possible to generate gene edited (GE) rabbit models analogous to those in
mice for use in research. Other GE large animal models including pigs and non-human primates have also
been generated, but the extended generation times, cost of housing, and high level of technical care required
greatly limit how widely they can be utilized. GE rabbits overcome many of these barriers and allow for the
development and expansion colonies in limited space and in a short time frame, making them a large animal
that is practical for wider adoption. More than 50 GE rabbit models have been published thus far highlighting
their usefulness, yet the cost of generating these models can be significantly higher than mice and rats. We
have developed a genome editing pipeline coupled with an improved rabbit reference genome for efficient
generation of GE rabbits. We have generated more than 40 different translationally relevant GE rabbit lines,
including whole body knockouts, humanization of disease associated alleles, and targeted knock-ins of
proteins of interest. Our lab has expansive expertise in characterizing these GE rabbits to study human
disease and have demonstrated that for multiple diseases rabbits are superior to rodents due to increased
translational relevance. However, rabbit models have increased costs and require advanced technical skills to
generate which has limited the overall number of GE rabbits generated and distribution of models. A
centralized resource to produce and distribution of GE rabbits would help overcome this limitation and increase
the implementation of rabbits in biomedical research. The overall mission of this grant is to leverage our
expertise to create the National Center of Rabbit Models for Translational Research (NCRMTR) and
expand access to GE rabbit models across the United States for biomedical research. We propose to generate
rabbit models with direct translational relevance to human diseases including cardiovascular, ocular,
neurologic, immunology and infectious diseases. This proposed centralized NIH resource center would
improve the generation of translationally relevant GE rabbits. We also aim to increase the dissemination and
maintenance of these rabbit models to the wider research community.

Public health relevance
PROJECT NARRATIVE The overall mission of this grant is to leverage our expertise to create the National Center of Rabbit Models for Translational Research (NCRMTR) and expand access to gene edited rabbit models across the United States for their use in biomedical research. We propose to generate gene edited rabbit models with direct translational relevance to cardiovascular, ocular, neurologic, immunology, and infectious diseases, to disseminate these models to researchers across the nation, and to provide training workshop to potential users on these novel models and related technologies.